Technical Assistance for Colorectal Cancer

This project will build upon the successes of the previous training by coordinating activities to offer at least 3 additional regional training opportunities for state, tribal and territorial teams (as established in collaboration with the established training planning committee).